DEVELOPMENT OF PATIENT CARE ENVIRONMENT THROUGH IMMERSIVE VIRTUAL REALITY. SBIR PHASE I TOPIC 020.

A multi-disciplinary team with expertise in biomechanics, rehabilitation games, virtual reality, and software engineering shall collaborate with clinical experts in rare diseases to develop a solution that allows rare disease patients to receive high-quality remote care. The solution incorporates an immersive VR clinic where patients and clinicians can engage naturally via avatars. A modular, extensible hardware interface shall facilitate integration of sensors, controllers and peripherals tailored to individual patient needs. Rehabilitation exercises shall be delivered as immersive games to improve engagement. Clinicians shall have the ability to create custom exercises by demonstrating a motion. The motion shall be adapted for the patient’s size and range of motion, then transformed into a game with customizable audiovisual stimuli. Health metrics from sensors shall be collected during both clinical interaction and gameplay and displayed in real-time. Longitudinal health analytics shall be accessible through a secure web dashboard to track patient outcomes. This solution shall reduce the burden of travel for patients with rare diseases and ensure access to high-quality, personalized teletherapy.